The Post-translational Synthesis of Hypusine In eIF5A and roles of eIF5A and polyamines in cell growth and animal development

Hypusine N-(4-amino-2-hydroxybutyl)lysine is a derivative of lysine that is formed post-translationally in the eukaryotic initiation factor 5A (eIF5A). Its occurrence at a single site in one cellular protein defines hypusine synthesis as one of the most specific post-translational modifications. Synthesis of hypusine involves two enzymatic steps: first, deoxyhypusine synthase (DHPS) cleaves the 4-aminobutyl moiety of spermidine and transfers it to the amino group of a specific lysine residue of the eIF5A precursor protein to form an intermediate, deoxyhypusine N-(4-aminobutyl)lysine. This intermediate is subsequently hydroxylated by deoxyhypusine hydroxylase (DOHH) to form hypusine in eIF5A. eIF5A, DHPS and DOHH are highly conserved in all eukaryotes and both enzymes exhibit a strict specificity toward eIF5A substrates. eIF5A promotes translation elongation globally by alleviating ribosome stalling and it also facilitates translation termination. Hypusine is required for the activity of eIF5A, mammalian cell proliferation and animal development. Homozygous knockout of any of the three genes, Eif5a, Dhps or Dohh leads to embryonic lethality in mice. eIF5A has been implicated in various human pathological conditions. A recent genetic study reveals that heterozygous germline EIF5A variants cause Faundes-Banka syndrome, a craniofacial-neurodevelopmental-malformations in humans. Biallelic variants of DHPS were identified as the genetic basis underlying a rare inherited neurodevelopmental disorder. Furthermore, biallelic DOHH variants also appear to be associated with neurodevelopmental disorder. The clinical phenotypes of these patients include intellectual disability, developmental delay, seizures, microcephaly, growth impairment and/or facial dysmorphisms. Taken together, these findings underscore the importance of eIF5A and the hypusine modification pathway in neurodevelopment in humans. To investigate the roles of eIF5A and DHPS in brain development, we have generated four conditional knockout mouse strains using the Emx1-Cre or Camk2a-Cre strain and examined the effects of temporal- and region-specific deletion of Eif5a or Dhps. The conditional deletion of Dhps or Eif5a by Emx1 promotor driven Cre expression (E.9.5, cortex and hippocampus) led to gross defects in forebrain development, reduced growth and premature death. On the other hand, the conditional deletion of Dhps or Eif5a by Camk2a-promoter driven Cre expression (postnatal, mainly in the CA1 region of hippocampus) did not lead to global developmental defects; rather, these knockout animals exhibited severe impairment in spatial learning, contextual learning and memory, when subjected to the Morris Water Maze test and a contextual learning test. In both models, the Dhps knockout mice displayed more severe impairment than their Eif5a knockout counterparts. The observed defects in brain, global development or cognitive functions most likely result from translation errors due to a deficiency in active, hypusinated eIF5A. Our study underscores the important roles of eIF5A and DHPS in neurodevelopment.